Administrative Core

PROJECT SUMMARY_CORE A
Recovery from viral pneumonia is a clinically important yet understudied process. Severe viral pneumonia due
to influenza A virus (IAV) or severe acute respiratory syndrome coronavirus 2 (SARS-CoV-2), the etiologic agent
of coronavirus disease 2019 (COVID-19), damages the lower respiratory tract to cause acute respiratory distress
syndrome (ARDS). While acute hypoxemic respiratory failure is a defining clinical feature in patients with ARDS,
advances in supportive care allow most patients to survive the hypoxemic phase of their illness. As a result, the
vast majority of patients with ARDS die from multiple organ dysfunction, including persistent respiratory failure,
days to weeks after the initial infection. Other than avoidance of additional lung injury, via low tidal volume
ventilation and a handful of other supportive therapies, there are no specific therapies for patients with viral
pneumonia/ARDS. A central hypothesis of this PPG is that the persistence of respiratory failure and the
development of multiple organ dysfunction in patients with ARDS is a consequence of the failure of normal
mechanisms of inflammation resolution and lung tissue repair. This hypothesis is clinically supported by a recent
analysis of patients enrolled in the ARDSnet where a “hyperinflammatory” endotype of ARDS patients was
associated with poor clinical outcomes, including death. We propose to investigate the process of recovery
from viral pneumonia with a focus on mechanisms that promote resolution of lung inflammation and
healthy repair of lung damage. Core A will assist the PPG investigators as they test this central hypothesis of
this PPG through a highly integrated and innovative set of experiments by focusing on five Specific Aims:
Specific Aim 1. To support communication between the Project Investigators, the Core Leaders, Collaborating
investigators, and the Internal and External Advisory Committee members.
Specific Aim 2. To provide a structure for the sharing of materials and dissemination of information between the
Project Investigators, Core Leaders and their Collaborators.
Specific Aim 3. To provide financial and regulatory oversight to the Project and Core Leaders and coordinate
their interactions with Institutional Core Services.
Specific Aim 4. To disseminate the discoveries made by the program project investigators through publications,
presentations and the sharing of resources to other institutions and other investigators.
Specific Aim 5. To foster an environment of collaborative interdisciplinary research and mentoring of students,
post-doctoral fellows and investigators.

Public health relevance
PROJECT NARRATIVE It is not required per instructions stated on the Funding Opportunity Announcement PAR-18-405, Section IV. Application and Submission Information, Administrative Core, Research & Related Other Project Information (Administrative Core), “Project Narrative: Do not complete.”